PHASE I STUDY OF THE INHALATION ADMINISTRATION OF ALPHA-PI BY AEROSOL WITH CYSTC

This is a Phase I study in which biochemical and clinical data will be collected to evaluate dosing, efficacy and safety of inhaled Prolastin in blocking the destructive effects of neutrophil elastase.